Development of a qualified pharmacokinetic bioassay to support preclinical and clinical studies of MM-008, a non-hormonal contraceptive antibody

Project Summary:
Nearly half of all pregnancies in the U.S. are unintended, and most occur in women who are not using
contraceptives. There are diverse reasons for not using contraceptives; one common reason is that many
women have a strong aversion to using exogenous hormones due to real or perceived side effects as well as
medical contraindications. It is likely that contraceptive use and satisfaction would substantially increase if
there were a non-hormonal, user-controlled contraceptive method that did not require use immediately prior to
intercourse, nor daily dosing. We believe we can create such a non-hormonal contraceptive based on
vaginal delivery of an anti-sperm monoclonal antibody (mAb) that agglutinates and traps sperm in mucus,
thereby preventing sperm from reaching the egg. This strategy, based on vaginal delivery of anti-sperm Ab,
was validated in animal models in the 1980’s-90’s, and, unlike contraceptive vaccines, enables consistently
reliable contraception and rapid reversibility. However, this strategy was not practical until recently due to
the high costs of mAb production, and modest agglutination potencies of prior anti-sperm IgGs. We have
developed a highly multivalent IgG, MM008, that targets a well-characterized and validated contraceptive
antigen universally present on all human sperm. MM008 is highly homogeneous and stable, and can be
produced at very high yields using conventional biomanufacturing processes. More importantly, MM008 is
exceptionally potent, possesing >16-fold greater sperm-agglutinaton potency than the best anti-sperm IgG
known in the literature. MM008 aggulutinates sperm even down to <100 ng/mL, and can reduce progressively
motile sperm by 99.9% in the sheep vagina within 2 mins, at a dose of just 33 ug per sheep. Furthermore,
we have shown that we can steadily release MM008 from a proprietary capsule-IVR system that sustains
highly effective concentrations of MM008 in the sheep vagina for over 20 days (more than adequate to cover
the fertility window in most women). We have also created vaginal film formulations of highly multivalent IgG
mAbs that achieved complete agglutination of all sperm within 2 mins in sheep. These highly promising results
motivated us to actively advance MM008 into the clinic. In this proposal, we seek to respond to the RFA HD-
22-018, and develop a highly sensitive and quantitative detection assay for measuring MM008 concentrations
in a variety of biological matrices relevant for IND-enabling and clinical studies. In Specific Aim 1, we will
establish a sandwich ELISA assay using a panel of anti-idiotype (anti-ID) Fabs against MM008. In Specific
Aim 2, we will further optimize and qualify the assays to quantify MM008 in matrices including human serum,
human cervicovaginal mucus, human mid-cycle endocervical mucus, and rat serum. These assays are part of
the critical path for advancing MM008 through IND-enabling GLP studies and early clinical studies. Successful
completion of the proposed work will accelerate our efforts to advance MM008 into the clinic.

Public health relevance
Project Narrative Unintended pregnancies account for half of all pregnancies in the U.S. and incur a cost burden of over $20B, due in part to a lack of suitable non-hormonal contraceptive options for many women. We are advancing MM008 as an antibody-based non-hormonal contraceptive, and now seek to develop assays that can support the preclinical and clinical development of MM008. Successful completion of this project will greatly accelerate our efforts to advance MM008 into the clinic as a reversible, long-acting, female-directed, non-hormonal contraceptive.